Deciphering unintended large gene modifications in gene editing for sickle cell disease

PROJECT SUMMARY
Sickle cell disease (SCD) is a single-gene disorder, affecting ~100,000 Americans and millions worldwide.
Existing pharmacological treatments may alleviate SCD severity but do provide a cure for SCD patients, and the
chronic transfusion therapy poses challenges due to alloimmunization and iron overload risks. Currently, the only
curative therapy for SCD is an allogeneic hematopoietic stem cell transplant (HSCT), typically from a matched
related donor, which is available to only ~15% of SCD patients. Recently, gene therapy and gene editing-based
autologous HSCT have emerged as potential curative avenues, offering an alternative approach to address
donor availability and graft-versus-host disease. Several CRISPR/Cas9 gene editing based therapies for SCD
are currently in clinical trials, by inducing fetal hemoglobin through BCL11A erythroid-specific enhancer targeting
or correcting the sickle mutation on the beta-globin gene (HBB). Although these SCD clinical trials show promise,
our recent studies found that three of the CRISPR gRNAs designed for treating SCD all induced unintended
large gene modifications with high frequencies at the Cas9 on-target cut-sites in SCD HSPCs, including large
deletions (LDs), insertions and complex local rearrangements. Given that two of these gRNAs (R-02 and
BCL11A) are being used in the ongoing clinical trials, it is imperative to comprehensively assess the biological
and clinical implications of these unintended gene modifications, and establish new strategies to mitigate
potential adverse effects, which are the primary goals of the Parent R01 grant. This Diversity Supplement will
expand upon the research proposed in the Parent R01 by supporting an underrepresented minority student to
conduct gene editing research for treating SCD. Aim 1 of this Diversity Supplement aims to expand the first aim
of the Parent R01, to determine the consequences of small indels, especially the frequencies and genotype-
phenotype relations of small in-frame indels at the Cas9 cut-site in HBB. Aim 2 of the Diversity Supplement will
expand Aim 3 of the Parent R01 to investigate the possibility of enhancing homology directed repair (HDR)
through the modulation of DNA repair pathways using small molecules, while simultaneously reducing LDs and
small in-frame mutations. It is expected that the studies supported by the Diversity Supplement will help establish
a better understanding of the consequences of HBB gene editing by CRISPR/Cas9, thus facilitating the
translation of genome editing based treatment of SCD.

Public health relevance
PROJECT NARRATIVE Sickle cell disease (SCD) is a genetic disease that affects millions of people worldwide. Although multiple SCD gene therapies are undergoing clinical trials, significant challenges concerning the safety and efficacy of CRISPR/Cas9 gene editing remain to be addressed, including the unintended small and large gene modifications at the Cas9 on-target cut-sites. This Diversity Supplement will provide the support to an underrepresented minority PhD student to determine the biological consequences of gene editing induced small in-frame mutations and investigate the impact of modulating DNA repair pathways in gene-editing based treatment of SCD.